Resuscitation using novel impedance threshold devices in pediatrics

DESCRIPTION (provided by applicant): Traumatic injury and hypovolemic shock are leading causes of death in children worldwide. Rapid, large volume crystalloid infusion and positive intrathoracic pressure ventilation resuscitation strategies often increase morbidity and mortality following hemorrhage. Augmenting negative intrathoracic pressure, even without fluid resuscitation, improves hemodynamic parameters and outcome in adult porcine hemorrhagic shock. Vascular biology, physiology, and tissue injury mechanisms change as the child matures from infancy through adolescence, and are distinctly different from adults. The optimal method to restore intravascular volume, prevent secondary organ damage, and prevent progression of reversible shock to irreversible circulatory collapse following severe blood loss in children is no known. Our central hypothesis is that use of intrathoracic pressure regulation (IPR), enhances negative intrathoracic pressure and thus will augment preload, improve cardiac output, enhance cerebral oxygenation, and delay or prevent the progression of reversible shock to irreversible circulatory collapse for infants and children. IPR therapy works by regulating intrathoracic pressures in non-breathing patients. It lowers intrathoracic pressures to subatmospheric levels (-5 to -12 cmH2O) after each positive pressure ventilation. Lowering intrathoracic pressure draws venous blood back to the heart and lowers intracranial pressure, thereby increasing systemic and cerebral perfusion. Cerebral perfusion is increased by decreased intracranial resistance to forward blood flow secondary to higher cardiac output. This novel therapy uses an external vacuum source to lower intrathoracic pressure and a switch to allow for intermittent positive pressure ventilation, as needed. The negative intrathoracic pressure is carefully titrated to optimize benefit with no evidence of harm to date. Building upon the successful Phase 1 studies that demonstrated improved 24 hour neurological survival when utilizing IPR technology in a pediatric porcine hemorrhage model, we propose to evaluate this innovative therapy in a carefully controlled clinical study in the pediatric population and measure key physiological variables including brain tissue oxygen levels. Specifically, the investigators propose to: 1) complete the development of and 510k clear an enhanced, miniaturized pediatric specific version of IPR therapy with variable vacuum levels that is housed in the expiratory limb of a standard ventilation circuit to be utilized in a clinical study, and 2) demonstrate proof of concep that application of intrathoracic pressure regulation (IPR) therapy will result in an increase in cardiac index in pediatric patients: a) with sepsis or b) who have undergone cardiac surgery for congenital heart disease (CHD) (single ventricle or tetralogy of Fallot). IPR resuscitation strategy has the potential to successfully combat hypovolemic shock and circulatory collapse, the most common cause of morbidity and mortality in children worldwide. PUBLIC HEALTH RELEVANCE: Trauma-induced hemorrhagic shock is the leading cause of hypotension in both children and adults. Multi-system trauma accounts for 50% of deaths occurring in children, most often from blunt trauma with severe hypovolemia progressing to circulatory collapse (CDC Vital Statistics 2003). For every pediatric patient that dies as a result of trauma, there are four survivors who are permanently disabled (approximately 100,000/year in the USA). Regardless of the etiology, intractable cardiovascular collapse continues to be a significant clinical challenge, especially in critically ill patients despite traditional fluid resuscitation and vasopressor agents. The main objective of this Phase 2 proposal is to provide proof of concept evidence in a carefully designed clinical study that application of intrathoracic pressure regulation (IPR) therapy will result in an increase in cardiac index and cerebral oxygenation in pediatric patients: a) with sepsis or b) who have undergone cardiac surgery for congenital heart disease (CHD) (single ventricle or tetralogy of Fallot). New approaches to treatment for this common medical emergency have the potential to reduce the high morbidity and mortality rates associated with severe hypotension. As such, this new device has the potential to be an important new advance in treating life-threatening hypotension and thereby reduce pediatric morbidity and mortality rates.

Public health relevance
Trauma-induced hemorrhagic shock is the leading cause of hypotension in both children and adults. Multi-system trauma accounts for 50% of deaths occurring in children, most often from blunt trauma with severe hypovolemia progressing to circulatory collapse (CDC Vital Statistics 2003). For every pediatric patient that dies as a result of trauma, there are four survivors who are permanently disabled (approximately 100,000/year in the USA). Regardless of the etiology, intractable cardiovascular collapse continues to be a significant clinical challenge, especially in critically ill patients despite traditional fluid resuscitation and vasopressor agents. The main objective of this Phase 2 proposal is to provide proof of concept evidence in a carefully designed clinical study that application of intrathoracic pressure regulation (IPR) therapy will result in an increase in cardiac index and cerebral oxygenation in pediatric patients: a) with sepsis or b) who have undergone cardiac surgery for congenital heart disease (CHD) (single ventricle or tetralogy of Fallot). New approaches to treatment for this common medical emergency have the potential to reduce the high morbidity and mortality rates associated with severe hypotension. As such, this new device has the potential to be an important new advance in treating life-threatening hypotension and thereby reduce pediatric morbidity and mortality rates.